Digital Pathology and Computational Image Analysis for Lupus Nephritis

Abstract
Nearly one third of all adults with Systemic Lupus Erythematosus (SLE) present with lupus nephritis (LN)
at diagnosis and up to two thirds manifest kidney involvement during the course of the disease with higher
prevalence in minority populations particularly those of African ancestry. Furthermore, as many as 10% of
patients with LN will progress to end-stage and require dialysis and/or kidney transplant. The ability to accurately
identify LN patients at risk for progression could shift much of the current management paradigm from treatment
to prevention. However, the prognostic significance of histopathologic classification of LN, the most current
arising from a collaboration between the International Society of Nephrology and the Renal Pathology Society
(ISN/RPS) in 2004 is controversial. Therefore, novel approaches are required to obtain continuous, quantitative
data to improve accuracy, reproducibility, and prognostic utility.
During the last decade, the rapid evolution of digital image technology has begun to challenge the established
light microscopy-based protocols. Digital pathology, a dynamic, image-based environment for the acquisition,
management, and analysis of information generated from digitized images, is emerging in the setting of clinical
trials and research, including kidney disease, but has yet to be comprehensively applied to lupus nephritis
biopsy interpretation in a large cohort. We hypothesize that digital pathology and image analysis approaches
will improve the prognostic utility of the kidney biopsy in lupus nephritis and allow more efficacious treatment
approaches. Thus, the goal of our proposal is to take advantage of the recent advancements of digital
pathology, deep learning, and machine learning, both supervised and unsupervised methods, and the broad
and extensive experience of the research team, and apply 1) quantitative morphology, 2) supervised computer-
aided deep learning image analysis algorithms with morphometric analysis, and 3) unsupervised machine
learning algorithms. To test our hypotheses, we will use our Digital Pathology Image Repositories (DPIR). We
have generated our DPIR from approximately 550 whole-slide scans of lupus nephritis biopsies from X patients
enrolled in the Accelerated Medicines Partnership (AMP) for Lupus Nephritis and the University of Michigan
Lupus Cohort. Data from the AMP cohort includes extensive clinical parameters obtained during longitudinal
follow up for 52+ weeks with predefined clinical outcomes of renal response. The Michigan Lupus Cohort
likewise includes detailed clinical information over several years already.

Public health relevance
Project Narrative Lupus nephritis is a significant burden to patients with systemic lupus erythematosus, but currently the prognostic utility of the kidney biopsy is lacking. Therefore, novel approaches are required to obtain continuous, quantitative data to improve accuracy, reproducibility, and prognostic utility. In this project we will apply detailed quantitative morphologic scoring, supervised computer-aided deep learning image analysis algorithms with morphometric analysis, and unsupervised machine learning approaches to establish improved methods of kidney biopsy interpretation in lupus nephritis.